Administration Core

Project Summary /Abstract - Administrative Core
This core provides the administrative leadership, management and oversight of the ALS-ENABLE Resource.
The Resource co-Directors will provide budget oversight for the whole project, set the scientific goals for the
whole program in collaboration with the deputy directors and Component leads, ensure milestones are met in a
timely manner, assess the progress in the individual Components, make significant changes in resource
composition if necessary, and report progress to NIH staff.